Project 2: Chromatin, eigenome, and nuclear fidelity in senescence and aging

Studies in animal models reveal that genetic differences and somatic mutations underlie longevity, but that
non-genetic contributions also play a major role. Numerous observations, including our observations, suggest
that epigenetic alterations occur as eukaryotes age. However, key questions remain, in particular, what are
driving mechanisms and genomic changes that underlie the cellular phenotypes that characterize senescence
and aging? Our hypothesis is that healthy aging involves homeostasis of the epigenomic landscape, which we
refer to as chromostasis, and that chromostasis fails during aging, leading to tissue deterioration and to
organismal death. Hence, genetic methods and pharmaco-therapeutics to enhance chromostasis are a
prominent feature across all collaborative projects of this P01 application and in this Project 2.
During the previous funding period we showed a key functional role of chromatin alterations in yeast
replicative aging and massive chromatin alterations in mammalian senescence. In the next funding period we
will explore and elucidate new chromatin regulatory pathways that alter genomic function in senescence and
aging, leading to loss of chromostasis. In preliminary studies, we newly identified chromatin regulators whose
reduction extends replicative lifespan, leading to new pathways that maintain epigenome and transcriptome
fidelity during aging. We also discovered that nuclear disruption and shedding of LADs/chromatin into the
cytoplasm during senescence and aging is perceived by a canonical cytoplasmic DNA sensing pathway,
cGAS-STING, which in turn triggers cellular immunity pathways and the SASP (the senescence associated
secretory phenotype) leading eventually to tissue damage during aging.
To uncover the mechanisms and physiological importance of these new chromatin regulators and
pathways in aging, we will carry out the following aims: 1. Investigate gene-internal cryptic transcriptional
initiation during aging. We hypothesize that gene-internal transcriptional activation sites disrupt normal initiation
at key longevity genes and lead to a global loss of transcriptional fidelity, contributing to reduction of
chromostasis. (2) Investigate aging-associated upregulation of histone acetylation creating new enhancers. We
hypothesize that dysregulated chromostasis licenses new enhancers during aging, leading to increased
transcription of anti-longevity genes. (3) Investigate loss of chromatin integrity during aging triggering
inflammation and autophagy of longevity chromatin regulators. Our preliminary findings show that
LADs/chromatin in the cytoplasm triggers aging-promoting cellular immunity pathways via cGAS-STING. In the
proposed studies, we will unravel the cGAS-STING pathway in promoting the SASP program in cellular
senescence and the chronic inflammation associated with natural aging.
This research will yield novel epigenetic mechanisms altering longevity, with potential for new therapeutic
targets for intervention in age-related diseases and to extend healthy lifespan.